PRECLINICAL MEDICATIONS SCREENING IN DEPENDENCE, AFFECT AND PAIN MODELS OF ALCOHOLISM

To perform blind testing of compounds supplied to NIAAA from industry suppliers, reference compounds, and compounds of interest in rats using standardized models of excessive alcohol drinking, pain and negative affect driven by alcohol dependence and provide analysis of said testing.